eMERGE IV Northwest: A partnership to evaluate the use of genomic information in health care

Project Abstract
This eMERGE IV (E4) supplement proposes extend the outcomes timeline for the prior
implementation of 10 “genomic risk assessment” (GIRA) scores in a network-wide set of
participants. These GIRAs include polygenic risk score (PRS) information, as well as risk
information, such as personal and family health history, environmental and social health
determinants, and physical and lab measures. Substantial challenges must be addressed
before genomic medicine is a part of standard medical care. The specific aims of our proposal
are designed to use an implementation science approach to advance the integration of genomic
data into clinical practice, including evaluation of patient perspectives and economic outcomes,
and broadening the impact of eMERGE through collaborations. The University of Washington
Medicine dedication to preventative health in a learning health system and broad expertise
across genomics, statistical, ethical, informatic, implementation, outcomes and economic
disciplines will support this multi-site clinical trial. We will continue our leadership in data-
cleaning and in the analyses of outcomes data.
Specific Aims:
Aim 1: Extend capture clinical outcomes for 10 GIRA on existing participants.
Aim 2: Evaluate the implementation, effectiveness, and economic utility of GIRA result return to
identify opportunities to improve human health for common disease.

Public health relevance
Free Note-taking Lined Paper from http://incompetech.com/graphpaper/notelined/